Pilot in vivo trial with T-cell-based delivery of immunostimulatory proteins

PROJECT SUMMARY
In this project, the investigators will explore the feasibility of using their cell-based platform for delivering
immunostimulatory proteins (IS) to achieve tumor regression in an in vivo pilot. Certain immunostimulatory
proteins have activity against the minimal disease in most solid tumors. However, their systemic delivery does
not permit sufficient concentrations to treat advanced disease, and their excess is associated with severe
toxicities. The challenge is to enable a localized dose at high concentration that can treat advanced disease
without undesired side effects. The team's mission is to harness the immune system to treat solid tumors. In
line with this mission, their objective in this project is to re-configure their current cell-based delivery system to
synthesize calibrated amounts of immunostimulatory proteins within the tumor microenvironment (TME); and
validate the antitumor effect in a high-grade serous ovarian cancer (HGSOC) mouse model. The feasibility of
the proposed experiments is supported by our previous publications and new preliminary data. Of particular
relevance to the present application is the localized expression of the immunostimulatory protein, which others
have shown to exert antitumor effects but is also toxic when delivered systemically. The team has already
modified tumor cells for reporting the activity of their cell-based delivery system in vitro and developed an
animal model with these tumor cells to assess the efficacy in vivo. The rationale is that the cell-based delivery
platform will enable high, TME-localized doses of the immunostimulatory protein, proportionate to the tumor
burden. The team plans to pursue this project in two aims: 1) Scale up the cells engineered to produce the
immunostimulatory protein upon engaging HGSOC cells; and 2) Demonstrate function in an HGSOC mouse
model. This project is significant because it will A) enable a strategy for site-specific delivery of high doses of
immunostimulatory proteins to target high tumor burden, and B) result in a process that can be scaled up
during preclinical studies in immunocompetent mice, as well as additional IND-enabling studies in compliance
with cGMP protocols. We believe this project is innovative and a substantive departure from the status quo
because instead of attempting to improve immunostimulatory protein bioavailability by exogenous delivery or
by inducing endogenous expression that is only effective against the minimal disease, we will use our cell-
based technology for enhancing immunostimulatory protein delivery to the TME. This will enable sufficient local
immunostimulatory protein concentrations to treat advanced disease.

Public health relevance
PROJECT NARRATIVE This research is relevant to public health because it utilizes our current platform of cell-based delivery to deliver proteins that can target cancer cells via autocrine signaling. This effort is relevant to NCI's mission because no approach is currently available for delivering calibrated amounts of therapeutic proteins specifically to the tumor sites and without impacting healthy cells.